CORE--SCIENTIFIC

The specific aims of the Scientific Core Project are: 1. To vigorously support scientific communication among Program Project investigators as well as communication of Program Project related research findings to persons outside the research team through a series of innovative activities including formal and informal seminars and electronic communication. 2. To make available to Program Project Investigators visiting scientists for consultation and review of progress. 3. To make available to Program Project Investigators an Advisory Committee for consultation on scientific progress. 4. To provide for Program Project Investigators a centralized resource for statistical consultation and coordinated data management.